Genomics and Cell Biology Core

PROJECT SUMMARY/ABSTRACT
GENOMICS AND CELL BIOLOGY CORE
The overall goal of the Genomics & Cell Biology Core will be to facilitate the application of cutting-edge genomics, bioinformatics, cell biology, and immunology techniques to nutrition and metabolic research. This will be accomplished by encouraging multi-disciplinary approaches and collaborations to study nutrition-related topics, and by overcoming the challenges to using complex and expensive techniques by providing appropriate consultation and training to NORC Investigators. The guiding philosophy of the Genomics & Cell Biology Core is that although many projects can be advanced by the use of sophisticated genomic and cell biology techniques, their expense and difficulty of first use represent a significant challenge. The Core is specifically designed to overcome this challenge by providing personalized consulting and training to NORC investigators that is not typically available in most NGS, genomics, bioinformatics, cell biology, or immunology core facilities. Following the retirement of Core Director Dr. Fred Ausubel (who has been the Director of Genomics Core since the original inception of the Center grant since 1994), Dr. Alessio Fasano, a renowned Celiac disease researcher and previously and Co-Core Director, has assumed the role of Director. The Co-Associate Director (Bioinformatics and Next Generation Sequencing) Dr. Ruslan Sadreyev, and Co-Associate Director (Cell Biology) Dr. Maureen Leonard will be in charge of respective parts of the Core. There are 5 specific Aims of the Core: 1) provide consultative services related to genomics, cell biology, and immunology research design; 2) provide space, technical personnel, and specific training and supervision for utilizing specialized techniques and equipment used in cell biology, immunology, and genomics research, including single-cell transcriptional and epigenomic profiling, assistance in the development of high-content high-throughput assays using automated microscopic imaging, fluorescent activated cell sorting, and development of animal models; 3) provide a variety of genomics-related services related to next-generation sequencing; 4) provide bioinformatic analysis of various types of high-throughput data, including bulk and single-cell RNA-Seq, ATAC-seq, ChIP- Seq, CUT&RUN, Hi-C, metagenomics, proteomics, as well as computational analysis of molecular pathways, networks and phenotypes; and 5) conduct enrichment tutorials and workshops in basic concepts in genomic, bioinformatic, cell biology, and nutrition and GI immunology-related techniques, and coordinate summer internships for undergraduates and medical students. This will be accomplished through the significant expertise of the Core Directors and staff, with the help of advanced instrumentation for bioinformatics analysis, most up-to-date next generation sequencing instruments, automated microscopy and imaging based high content screening assays, a variety of equipment for carrying out immunological, cell biology, and morphology- related assays.